FFM Compliance and Enforcement Expansion Supplement

Ohio Department of Agriculture MFRPS FFM Compliance and Enforcement Expansion
Supplement Summary/Abstract
The purpose of the Ohio Department of Agriculture, Division of Food Safety (ODA FS)
participating in the Compliance and Enforcement Expansion Supplement portion of the FFM
grant is to advance public health by developing a comprehensive approach to prevention,
identification, containment, and removal of adulterated, contaminated, or misbranded products
in the marketplace.
We intend on accomplishing this by expanding our investigational techniques to include
traceback/forward training, conducting aseptic sampling training, development of a more
thorough recall policy (to include effectiveness checks and recall status reports), utilizing our
enforcement tools, when necessary and enhancing our already strong relationships with FDA
and state inspection programs to work toward a more integrated food safety system.

Public health relevance
Ohio Department of Agriculture MFRPS FFM Compliance and Enforcement Expansion Supplement Narrative Participation in the FFM compliance and Enforcement Expansion Supplement will allow the Ohio Department of Agriculture, Division of Food Safety (ODA FS) to serve the consumers in Ohio and throughout the US more quickly and effectively by working with the FDA and other state programs to remove adulterated, contaminated, or misbranded food from the marketplace.